A Multilevel Investigation of Migration and Dementia Risk Among Mexican Americans

ABSTRACT
The US-Mexico migration corridor is one of the busiest in the modern era. In the United States, over 15 million
adults ages 50+ are foreign-born, most of Mexican origin. As immigration becomes more common, we urgently
need better evidence on its health effects, social contexts that may remediate or exacerbate the health risks of
immigrants, and biological mechanisms of these effects. Relatively little is known about the determinants of their
risk for Alzheimer’s disease or related dementias (ADRD) among Mexican Americans. In addition to
socioeconomic disadvantage, Mexican Americans may be exposed to unique migration-related stressors and
discriminatory experiences (e.g., exposure to anti-immigration sentiments). Embodiment of migration-related
stressors may manifest through accelerated biological aging or increased inflammation which, in turn, may
elevate ADRD risk. Quantifying ADRD risk in Mexican Americans is not straightforward, however, due to the
methodological challenge of disentangling the effect of migration from the selection factors that predict migration
itself and ADRD. If unaccounted for, predictors of healthy in-migration and unhealthy out-migration (often offered
as reasons for the Latino paradox) may mask true health disadvantages due to immigration. Additionally,
research on the social epidemiology of migrant health, ADRD in particular, has underexamined complex concepts
such as the socio-political climate surrounding migration and its biosocial embodiment. Addressing these gaps
in the field and our knowledge demands methodological innovation and assessment of multilevel drivers of
migration and risk of ADRD, from policy to biology. Further, most data sources cannot disentangle
selection/confounding from causation because they include only migrants (i.e., they enroll US residents and
compare migrants to U.S.-born individuals). Often, the outcomes of those born in the communities of origin who
do not migrate are never represented. In this proposal, we will leverage our team’s previous infrastructural work
(under RF1AG055486) that built a binational dataset pooled across the US (from the Health and Retirement
Study or HRS) and Mexico (from the Mexican Health and Aging Study or MHAS) that spans the life course
(beginning from birth until age at migration or study entry). This dataset has built-in longitudinal propensity scores
(weights) capturing pre- and post-migration characteristics, which is a crucial step for correcting bias due to
selective migration, a major barrier to the effective study of migrant health. Using this unique dataset and
innovative life course models, we propose to (Aim 1) estimate the effect of migration, residence in the US, and
acculturation on cognitive function and dementia risk, (Aim 2) evaluate how different immigration policy climates
and social contexts modify the effects of migration, and (Aim 3) assess embodiment through biosocial pathways.
We will use the Harmonized Cognitive Assessment Protocol (HCAP) which will allow major improvements on
what was previously possible in this binational cohort. The study will provide novel insights into the multilevel
drivers and underlying mechanisms of migration’s effects on ADRD.

Public health relevance
Project Narrative Mexico-US immigration is increasingly common and Mexican Americans are one of the fastest growing and aging populations in the United States, yet methodological challenges rooted in migrant selection and the Latino paradox hamper understanding of the effects of their migration experience on ADRD risk. A pooled binational life course dataset with harmonized cognitive outcomes and built-in longitudinal propensity scores of healthy in- migration and unhealthy out-migration provides a unique opportunity to rigorously examine these relationships. In this study, we leverage our previously created pooled binational life course dataset to estimate the association of migration and ADRD risk using the newly improved HCAP data, assess how the socio-political context influences this relationship, and examine underlying biosocial pathways.